Technology-supported, measurement-based supervision for Motivational Interviewing

Project? ?Summary/Abstract Millions? ?of? ?Americans? ?receive? ?evidence-based? ?counseling? ?for? ?substance? ?use? ?problems? ?each? ?year.? ?Many evidence-based? ?treatments? ?for? ?substance? ?abuse? ?are? ??talk? ?based?? ?therapies,? ?such? ?as? ?motivational? ?interviewing (MI),? ?but? ?the? ?existing? ?research-based? ?methodology? ?for? ?evaluating? ?counseling? ?quality? ?is? ?to? ?record? ?sessions? ?and use? ?human? ?rating? ?teams? ?to? ?evaluate? ?them.? ?However,? ?using? ?humans? ?as? ?the? ?assessment? ?tool? ?via? ?behavioral coding? ?is? ?prohibitive? ?in? ?cost? ?and? ?time,? ?can? ?be? ?error? ?prone,? ?and? ?is? ?virtually? ?never? ?used? ?in? ?the? ?real? ?world. Technology? ?is? ?needed? ?that? ?can? ?analyze? ?the? ?speech? ?patterns? ?and? ?spoken? ?language? ?of? ?counseling? ?sessions, provide? ?automatic? ?and? ?intuitive? ?quality? ?scores,? ?and? ?summarize? ?these? ?in? ?actionable? ?feedback.? ?Rapid, performance-based? ?quality? ?metrics? ?could? ?support? ?training,? ?ongoing? ?supervision,? ?and? ?quality? ?assurance? ?for millions? ?of? ?evidence-based? ?counseling? ?sessions? ?for? ?substance? ?abuse? ?each? ?year. Lyssn.io?? ?is? ?a? ?start-up? ?targeting? ?the? ?development? ?of? ?implementation-focused? ?technology? ?to? ?support evidence-based? ?counseling.? ?? ?Our? ?goal? ?is? ?to? ?develop? ?innovative? ?health? ?technology? ?solutions? ?that? ?are? ?objective, scalable,? ?and? ?cost? ?efficient.? ??Lyssn.io?? ?includes? ?expertise? ?in? ?speech? ?signal? ?processing,? ?machine? ?learning, user-centered? ?design,? ?software? ?engineering,? ?and? ?clinical? ?expertise? ?in? ?evidence-based? ?counseling.? ?Previous NIH-funded? ?research? ?laid? ?a? ?computational? ?foundation? ?for? ?generating? ?MI? ?quality? ?metrics? ?from? ?speech? ?and language? ?features? ?in? ?MI? ?sessions,? ?and? ?led? ?to? ?a? ?prototype? ?of? ?a? ?clinical? ?software? ?support? ?tool,? ?the? ?Counselor Observer? ?Ratings? ?Expert? ?for? ?MI? ?(CORE-MI). The? ?current? ?Fast-Track? ?SBIR? ?proposal? ?includes? ?Phase? ?I,? ?which? ?will? ?focus? ?on? ?understanding? ?clinical workflows,? ?assessing? ?usability,? ?and? ?initial? ?validation? ?of? ?machine? ?learning? ?of? ?MI? ?fidelity? ?measures? ?in? ?the? ?opioid treatment? ?program? ?at? ?Evergreen? ?Treatment? ?Services? ?(ETS)? ?clinic? ?in? ?Seattle,? ?WA.? ?Phase? ?II? ?will? ?focus? ?on? ?robust validation? ?of? ?the? ?speech? ?and? ?language? ?technologies? ?underlying? ?the? ?CORE-MI? ?tool,? ?and? ?development? ?of? ?scalable supervision? ?protocols? ?that? ?integrate? ?CORE-MI? ?supported? ?feedback? ?for? ?counselors.? ?Finally,? ?we? ?will? ?conduct? ?a quasi-experimental? ?evaluation? ?of? ?CORE-MI? ?supported? ?supervision? ?and? ?training? ?at? ?a? ?second? ?ETS? ?clinic? ?in? ?the Puget? ?Sound,? ?focusing? ?on? ?acceptability,? ?usability,? ?and? ?adoption,? ?the? ?impact? ?on? ?supervision,? ?improved? ?MI? ?fidelity and? ?preliminary? ?evidence? ?of? ?increased? ?client? ?retention.? ?? ?The? ?successful? ?execution? ?of? ?this? ?project? ?will? ?break? ?the reliance? ?on? ?human? ?judgment? ?for? ?providing? ?performance-based? ?feedback? ?to? ?MI? ?and? ?will? ?massively? ?expand? ?the capacity? ?to? ?train,? ?supervise,? ?and? ?provide? ?quality? ?assurance? ?in? ?MI? ?for? ?substance? ?abuse.

Public health relevance
Project Narrative Most evidence-based treatments for substance abuse are in-person psychotherapy and counseling interventions, such as motivational interviewing. There are currently no methods for evaluating the quality of such counseling interventions in the real world to support training, supervision, and quality assurance. Building on an existing prototype, Lyssn.io – a technology start-up focused on scalable and cost-efficient human-centered technologies – will enhance and evaluate a cloud-based, HIPAA-compliant clinical support software tool that uses automated speech recognition and machine learning in an community based opioid replacement clinic.